Universal Edited MRS at 3T

Project Summary
Hadamard-encoded edited MRS allows simultaneous in vivo detection of multiple low-concentration
neurometabolites in a single experiment. Methods developed in the last funded period of this grant are being
applied in the HBCD study, a large national study of childhood development (~7,000 infants). In this renewal
period, we will acquire the same acquisition protocol in a whole-lifespan cohort in order to reveal
neurochemical changes in development and aging. Methodologically, we will then extend the utility of edited
MRS into challenging areas of the brain by addressing the long-standing issue of out-of-voxel (OOV) echoes.
We will optimize acquisitions to reduce the impact of OOV echoes for each challenging region and develop
modeling strategies to minimize their impact on metabolite quantification. We will also develop intelligent
acquisitions that can detect OOV signals in real-time as the sequence is being acquired and adjust the
acquisition responsively to reduce OOV signals. Finally, we will continue the on-going work to disseminate
methods developed during prior grant periods, upgrading code as scanners update and porting new advances
back into older code so collaborators can benefit.

Public health relevance
Project Narrative Edited magnetic resonance spectroscopy (MRS) allows us to measure levels of biologically interesting chemicals in the brain; this project has allowed us to develop edited MRS methods with researchers around the world. In this renewal period, we will study these brain chemicals in a cohort that covers the entire lifespan, address the longstanding technical challenge of unwanted signals, and continue to share methods with collaborators.